Genetic and epigenetic mechanisms of developmental gene regulation

Project Summary/Abstract
Nearly all cells in our bodies contain the same genome, and thus each of them has the capacity to adopt one of
many cell identities. Normal development is characterized by progressive restriction in cell identity from
multipotent progenitor cells toward terminally differentiated cells. Most cells choose a single identity and maintain
it over time. However, defects in cell fate determination or maintenance can allow cells to escape the restrictions
on cell identity, endowing them with new properties that cause disease. For this reason, the steps leading to
disease have been described as development gone awry. More importantly, it suggests that cells proceed down
the path to disease by inappropriately accessing genetic information controlling cell identity. Thus, studying the
mechanisms controlling access to genetic information during normal development can inform how deregulation
of these mechanisms contributes to disease. My lab studies two different regulatory layers controlling access to
DNA-encoded information and their importance in controlling gene expression. Research during the term of this
grant will interrogate the mechanisms underlying (1) how chromatin-based packaging of transcriptional
enhancers determines where and when transcription factors bind DNA to switch genes on or off, and (2) how
modifications of histone proteins contribute to chromatin organization and transcriptional control. DNA is wrapped
around histone proteins to form nucleosomes, the repeating unit of chromatin. Nucleosomes are barriers to
transcription factor binding, inhibiting early steps of gene activation. Thus, understanding how chromatin is made
accessible to transcription factors is necessary for understanding gene control. More importantly, returning open
chromatin to a closed state and reinstating this barrier is critical for preventing gene activation at the wrong time
or place. However, the mechanisms controlling chromatin closing are uncharacterized. We have uncovered a
temporal cascade of transcription factors, which we term “chromatin gatekeepers” due to their requirement for
opening and closing access to enhancers, that we study to decipher these mechanisms. We will also investigate
how information about decisions made earlier in development is propagated over time. A key to unlocking this
question is a unique genetic resource we recently generated that enables us to directly test the function of
histones. Histones are subject to a diverse array of post-translational modifications (PTMs) that are thought to
carry epigenetic information to control DNA-templated processes, including transcription. However, evidence
supporting the role of histone PTMs in animals is largely correlative due to the difficulty in creating mutant histone
genotypes in animals. Drosophila is distinct among animal models in that the histone genes reside at a single
locus in the genome. We can replace the endogenous histone genes with tailor-made versions, thereby providing
us with the first opportunity to distinguish between regulatory information that is directly encoded in the DNA
sequence and information that is epigenetically propagated. We will employ this approach to interrogate the role
that histone PTMs play in transcriptional regulation and in control of 3D genome organization.

Public health relevance
Project Narrative Successful completion of development requires tight control of gene expression. The research described in this proposal will examine the basic mechanisms that determine where and when the DNA regulatory elements controlling gene expression are used. Defects in gene regulation can endow cells with new properties that lead to disease; therefore, knowledge of the underlying mechanisms is important for human health.